Inactivation of hyperpermeability after ischemia-reperfusion induced inflammation

DESCRIPTION (provided by applicant): Increased microvascular permeability is a hallmark of inflammation and characterizes the initial events in ischemia-reperfusion. Previous research has focused on how to prevent the onset and the maintenance of the elevated permeability. We propose to investigate the mechanisms that inactivate hyperpermeability in the inflammatory phase of ischemia-reperfusion and return it to baseline levels in striated muscle. We hypothesize that after a hyperpermeability phase, the postischemic muscle begins a process to inactivate hyperpermeability and restore the physiological barrier properties of the microvascular wall. We further propose that Epac and Rap-1 serve as `Barrier Enhancing Factors' and participate in the hyperpermeability-inactivation process. Maintenance of microvascular barrier properties is mainly regulated through factors controlling proteins that form intercellular adhesions. Cell-cell adhesion, in turn is regulated in many cells in part through feed-back signaling between small GTP-binding proteins and junctional proteins. The Specific Aims designed to test the hypothesis are: Specific Aim 1: To investigate the timed inactivation of hyperpermeability after ischemia- reperfusion induced inflammation. Specific Aim 2: To determine whether activation of Epac/Rap-1 inactivates hyperpermeability in ischemia-reperfusion. Specific Aim 3: To test whether endothelial Epac/Rap-1 signaling is responsible for restoration of barrier integrity. We will apply microscopy, computer-assisted image analysis and molecular biology approaches in striated muscle (in vivo) and in endothelial cells to elucidate the role of these relevant cAMP-stimulated factors in the inactivating phase of hyperpermeability in postischemic muscle. We will use endothelial cells exposed to oxygenation and reoxygenation to explore the cellular mechanisms. The body response to inflammation and to ischemia reperfusion is highly complex and involves well orchestrated molecular mechanisms. Knowledge of the timing between hyperpermeability and its physiological inactivation in ischemia-reperfusion should provide a window of opportunity for interventions promoting inactivation of hyperpermeability to prevent excessive edema, compartment syndrome and tissue damage. Our results should be of clinical relevance to revascularization in elective and emergency vascular surgery.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our results will advance current understanding of the molecular mechanisms involved in the inactivation of increased permeability. The emerging data will be clinically relevant in the settings of revascularization. The results could serve as a basis for new adjuvant therapeutic approaches to assist vascular surgeons in preventing damage and returning function to postischemic muscles. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS. Hyperpermeability, a hallmark of inflammation, is among the important initial events in the microvascular response to ischemia-reperfusion (I-R). Knowledge of the dynamics of this fundamental process and the development of adequate therapies has focused on investigating how to prevent the onset and the maintenance of the elevated permeability. Thus, we have learned much about how to counteract or inhibit the action of specific agents that elevate permeability. Less effort has been devoted to understanding the mecha- nisms that normally enhance the barrier properties of the microvascular wall; knowledge that once acquired might be applied to prevent or terminate excessive increases in microvascular permeability. After a period of controversial reports, it seems now established that hyperpermeability in response to an inflammatory chal- lenge is regulated by endothelial cells (EC) mainly through endothelial NO synthase (eNOS) (30, 33, 34, 42, 58, 78). eNOS-modulated processes are orchestrated in synchrony with cell contraction and junctional re- organization induced by polymorphonuclear leukocytes (10, 79, 82). On the other hand, maintenance of barrier properties is mainly regulated through factors controlling proteins that form intercellular adhesions. Cell-cell adhesion is regulated through feed-back signaling between small GTP-binding proteins and junctional proteins (1, 7, 72), an area of current active investigation. Our laboratory reported several years ago that hydroxyethyl starch (HES), Iloprost (an analog of prostacyclin), and inhibition of the synthesis of TNF-α (tumor necrosis factor-alpha) attenuated the hyperpermeability caused by I-R in striated muscle (4, 56, 70). In addition, we documented that papaverine caused vasodilation but did not increase microvascular permeability (32). Recent reports provide an understanding of the subcellular mechanisms associated with Iloprost, papaverine and HES that may contribute to the maintenance of the in- tegrity of the endothelium under conditions of inflammatory stress. These mechanisms involve cAMP-activated pathways, in particular Epac/Rap1 and Rac-1 pathways, which are independent of cAMP-stimulation of PKA (14-16, 20, 23, 24, 27, 29, 63, 64). This proposal is a logical extension of our laboratory's work in the field of I- R induced inflammation. An axiom among regulatory biological principles is that the steady state of systems is maintained by counter- balancing factors. Thus, physiological levels of microvascular permeability are maintained by a balance be- tween endothelial signaling factors that enhance and signaling factors that reduce the wall barrier properties. We propose to test this biological principle in the context of I-R induced inflammation. We hypothesize that after a hyperpermeability phase, the postischemic muscle begins a process to inactivate hyperperme- ability and restore the physiological barrier properties of the microvascular wall. We propose that the small GTP-binding proteins Epac/Rap1 serve as `Barrier Enhancing Factors' and participate in the hyperper- meability-inactivation process. The Specific Aims designed to test the central hypothesis are: Specific Aim 1: To investigate the timed inactivation of hyperpermeability after ischemia-reperfusion induced inflammation. These data are not available in vivo; thus, this aim will provide important descriptive data re- garding the natural history of the development and inactivation of hyperpermeability in the inflammatory phase of I-R in striated muscle. Specific Aim 2: To determine whether activation of Epac/Rap1 inactivates hyperpermeability in ischemia- reperfusion. We will apply intravital microscopy in conjunction with image analysis and molecular biology ap- proaches to elucidate in vivo the role of these two relevant small exchange factors-GTPases in the inactivating phase of hyperpermeability in postischemic muscle. Specific Aim 3: To test in endothelial cells (EC) in culture whether Epac/Rap1 signaling is responsible for res- toration of barrier integrity following hypoxia and reoxygenation. We will mimic ischemia-reperfusion by expos- ing EC to hypoxia and reoxygenation. Completion of this aim will assist in identifying endothelial cells as key regulatory cells in the hyperpermeability inactivation process.